Genomically rewritten and tailored humanized mouse models for various organ disorders

Summary
This proposal leverages Big DNA technology to produce mouse models of a variety of human diseases. The
underlying hypothesis tested in our earlier work and continued in this proposal is that changes in human non-
coding DNA that underlie human disease susceptibility will translate into appropriate disease phenotypes in
the mouse when the entire human genic region of interest is inserted into a predefined location in the mouse
genome. We refer to such animals as GREAT-GEMMs (Genomically Rewritten and Tailored Genetically
engineered moused models). Furthermore, GREAT-GEMMs will serve as a resource for testing therapeutic
interventions against human disease. These animals will be uniquely useful for cutting edge therapies like
gene therapies, CRISPR based therapies and allele specific oligonucleotide (ASO) therapies which depend on
exact human DNA sequences as targets. Our work is based on our recently developed ability to synthesize and
precisely edit 50-300+ kilobase DNA constructs, and then to precisely delivery them to mouse embryonic stem
cells (mESCs) and subsequently produce mouse models for human disease.

Public health relevance
Narrative An “instruction manual” on when and where genes are to be expressed can be significantly larger than gene itself, even 100 times as big. This makes deciphering the causes of genetic disease a challenge. Our group has developed methods to probe this “dark matter of the genome” and will use this proposal to make 16-24 mouse models of human disease susceptibility for a broad range of human diseases affecting the brain, the eye, cardiovascular disease and the immune system.